The schizophrenia-associated 3q29 deletion: genetic architecture of behavioral phenotypes

Summary
3q29 deletion syndrome is caused by a typically de novo 1.6 Mb deletion of 21 genes. The syndrome is
associated with an astonishing 40-fold increased risk for schizophrenia, as well as cognitive disability, a high
rate of autism and social disability, executive function deficits and pronounced prevalence of attention deficit
hyperactivity disorder (ADHD), clinically significant graphomotor weakness, and manifestation of anxiety
disorders. The factors that contribute to this phenotypic heterogeneity are not understood. We propose to
evaluate 200 individuals with the 3q29 deletion, to better define phenotypic manifestations and identify risk
modifiers for key phenotypes. In particular, we seek to understand how polygenic background and sex of the
proband may modify risk for psychosis, cognitive disability, social functioning, and other phenotypes. To
facilitate our evaluation and attenuate ascertainment bias, we have developed a remote phenotyping battery,
which does not require travel to a testing site. This remote battery removes barriers to participation for our
study subjects and dramatically reduces costs, improving the efficiency of our study. Using this validated
phenotyping protocol, we will characterize 200 new study subjects with the 3q29 deletion, and identify the full
phenotypic spectrum, sex-dependent phenotypic risks and significant comorbid relationships. We will also
phenotype biological parents to contextualize the burden of illness in 3q29 deletion syndrome relative to
departure from mid-parental phenotype, and clarify the range of phenotypic heterogeneity in 3q29 deletion
syndrome. We will collect DNA from our study subjects, to directly test the contribution of polygenic risk to
selected phenotypes. Finally, in a collaboration with the NIMH-sponsored Genes 2 Mental Health Network, we
will compare the phenotypic spectrum and risk modifiers of 3q29 deletion syndrome with >2,000 samples from
other genomic disorders associated with neurodevelopmental and neuropsychiatric disorders, including
22q11.2 deletion and duplication, 16p11 deletion and duplication, 1q21 deletion, and others. At the end of this
project, we will have a comprehensive survey of 3q29 deletion associated phenotypes, an understanding of
how sex and polygenic background may increase or attenuate phenotypic risks in 3q29 deletion syndrome,
and an appreciation for how the 3q29 deletion compares to the broader landscape of rare genetic disorders
associated with developmental brain disorders. All genotype and phenotype data from this study will be shared
in publicly-available databases, including dbGaP and NDAR.

Public health relevance
Narrative 3q29 deletion syndrome is associated with a high risk for schizophrenia and other neurodevelopmental and psychiatric disorders, but the reasons for this heterogeneity are not well understood. We will evaluate these phenotypes in 200 individuals with 3q29 deletion syndrome, and assess how sex and background genetic factors may influence the phenotype. We will also compare our data with >2,000 samples from other genomic disorders, to understand how the 3q29 deletion compares to the broader landscape of rare genetic disorders associated with developmental brain disorders.